Pulmonary Focused Foundations in Innovation and Scholarship (PuFFInS)

PROJECT SUMMARY
This is a renewal application of a T32 postdoctoral research training program in basic research, translational
research, clinical research, clinical trials and health service research, and telehealth research relevant to
improving lung health within the southeastern United States. The goal of the Pulmonary Focused
Foundations in Innovation and Scholarship (PuFFInS) Training Program is to recruit, train and ensure that
the next generation of investigators have the skillsets needed to improve the healthcare and outcomes for
individuals with lung diseases with particular emphasis on lung cancer prevention, screening and
implementation, critical care, and rare lung diseases, including pulmonary fibrosis, sarcoidosis and cystic
fibrosis. Our interactive and interdisciplinary PuFFInS Training Program brings together a spectrum of well-
funded investigators across the Medical University of South Carolina, including clinician researchers,
epidemiologists, and cell biologists. The training program is structured to help trainees obtain the necessary
competencies and expertise for sustained careers in pulmonary medicine in a flexible framework that
accommodates a diverse range of prior education/experience. PuFFInS trainees may matriculate into one of
two research tracks with a foundation in innovation and entrepreneurship: a Clinical Science Research Track
focused on clinical trials, health service research, and telehealth research, and a Basic Science Research
Track. Training will be outlined in each Fellow’s Individualized Development Plan and guided by their selection
of a Primary Mentor in a pulmonary-related research area and Secondary Mentor to provide a complimentary
interdisciplinary scientific approach or clinical area of expertise. PuFFInS trainees will also benefit from core
and selective training options that include formal course work, workshops, training in the responsible conduct
of research, and retreats. The application requests support for 4 PuFFInS trainees per year. PuFFInS trainees
will be on the research training grant for two years. The Program Steering Committee will review and approve
the selection and annual re-appointment of PuFFInS trainees based on specified criteria and evaluation data.
A multi-year assessment plan will be used to: 1) assess each trainee’s performance and experience in the
program and subsequent development and productivity; 2) assess the effectiveness of the mentors and
mentee-mentor relationships; 3) enable program leadership to determine if the objectives of the program are
being achieved; and 4) inform strategic direction for future program development.

Public health relevance
PROJECT NARRATIVE There is an urgent, unmet public health need to improve outcomes for chronic lung diseases, which disproportionately impacts the Southeast. This program will provide research training for investigators who will ultimately improve the healthcare and outcomes for individuals with lung diseases with particular emphasis on lung cancer prevention, screening and implementation, critical care, telehealth, and rare lung diseases, including pulmonary fibrosis, sarcoidosis and cystic fibrosis. Training in innovation and entrepreneurship will enable investigators to create innovative solutions to challenges in health, to catalyze interdisciplinary entrepreneurial efforts, and ultimately become change agents to address national and global health problems.